Bone as a Sensor of and Responder to Stress During Aging

Project summary
Aging is associated with a myriad of deleterious physical consequences. Among them, we as a group have
recently focused our work on the decreased ability to respond to stress whether it is endogenous, e.g., sex
steroid deprivation or exogenous through bacterial infections or various stressors. This is why the focus of this
P01 application is to characterize the role of bone as an endocrine organ in sensing and responding to stress.
This work is largely motivated by the fact that we have in the past 2 years accumulated in vivo and through the
study of gain and loss of functions animal models, numerous experimental evidence that the two molecules
that this group of investigators characterized as bone-derived hormones, osteocalcin, and lipocalin 2, are
involved in allowing the body to respond to stressors of various kinds. In pursuing this line of investigation, we
have also identified one molecule glutamate, as a regulator of both osteocalcin and lipocalin 2 release during a
stress reaction. At the same time, this work was unfolding another member of the original group of
investigators that worked together in this PO1 application has gathered numerous preliminary evidence that an
endogenous stressor such as estrogen deprivation affects β cell number and biology in an osteocalcin-
dependent manner. Lastly, a new member of our group Dr. Lori Zeltser, an accomplished neuroscientist and
an expert in the biology of appetite and thermogenesis, is revisiting at the most fundamental mechanistic level
an observation two project leaders in the PO1 application, Drs. Ducy and Karsenty had made over 13 years
ago. This observation is that osteocalcin favors energy expenditure and as a result the ability to protect from
another stressor, diet-induced obesity. These broad arrays of preliminary results obtained over the course of
13 years converge on asking the following fundamental and novel question that we propose to address in this
application. Is bone as a sensor and responder to stress throughout life? To address as many aspects as
possible of this question, we intend to blend in this application the bone biology endocrinology and
neuroscience expertise of its four PI’s. Therefore, to address the broad questions we are asking, we propose
to test the following Specific Aims: To determine whether the regulation of the release of osteocalcin can be
harnessed to prevent or rescue manifestations of aging (Project#1) To determine whether bone is an acute
inflammation-sensing organ that mounts lifesaving anti-inflammatory responder through lipocalin 2 secretion by
osteoblasts (Project#2). To determine whether estrogen deprivation at menopause enhances the production of
osteocalcin and as a result may affect β cell biology and glucose homeostasis (Project#3). To investigate
mechanistically whether the decrease in circulating osteocalcin during aging is, a least in part, responsible for
the dysregulation of thermogenesis seen during aging (Project#4).

Public health relevance
Project Narrative - Overall There are now increasing numbers of evidence that bone through the hormones, osteocalcin or lipocalin 2, can be involved in the body reactions to various types of stressors. Moreover, some of the functions that are promoted by osteocalcin decrease with age. This application aims at exploring the relationship between bone and stress response and at using this knowledge to combat manifestations of aging.